Age, Gene/environment Susceptibility Study In Iceland - Ocular Component

In the AGES cohort we are estimating the prevalence and risk factors of eye disease as well investigating possible functional correlates in persons exhibiting clinical signs in other organ systems. A follow-up examination on a subset of 4,000 elderly individuals in this cohort was initiated at the end of 2007 with the examination to run through September 2011. A subgroup of the AGES participants was genotyped in 2009. AGES is a member of the Cohort for Heart and Aging Research in Genomic Epidemiology (CHARGE) consortium. As such, it is involved in genetic meta-analysis for discovery or replication of genetic variants of disease. For more information on the study, see http://www.hjarta.is/english/ages. Refer to project bibliography on the study website for published papers and papers in press. See also annual reports AG007380 and AG006000(Dr. Harris).